Elucidating the legacy of early parent-child relationship: A new developmental synthesis of temperament, internal representation, and behavior

ABSTRACT
The overarching goal of this research is to promote children’s positive socioemotional pathways and to prevent
maladaptive pathways. We elucidate why some children embark on positive paths toward prosocial,
internalized, rule-abiding conduct, and robust social competence, whereas others enter maladaptive paths
toward callousness, disregard for conduct rules and others’ feelings, antisocial behavior, and impoverished
competence. We focus on the parent–child early relationship, formed in the first years of life, as an influential
source of the divergent paths, and we longitudinally chart its complex, indirect yet powerful, long-term legacy.
Drawing from our extensive research, correlational and experimental, in low- and high-risk families, we propose
that although early relationship may not have long-term unqualified, direct effects, it nevertheless serves as a
powerful moderator of future parent–child unfolding dynamics. Specifically, early relationship can set the stage
for an adversarial, negative cascade. In suboptimal, insecure parent–child dyads, the child’s difficult
temperament easily triggers the parent’s negative, harsh, power-assertive control, which, in turn, leads to
detrimental child outcomes. In contrast, an early optimal relationship sets the stage for positive, cooperative,
effective socialization, and defuses risks of negative cascades. We proposed that parents’ and children’s
differing internal representations, expectations, and perceptions of each other (Internal Working Models, IWMs)
that characterize suboptimal and optimal relationships and come to guide parents’ and children’s behavior and
interactions are the key mechanisms that account for the divergent cascades. We are testing this framework in
an ongoing study of 200 community mothers, fathers, and children, richly assessed at 8, 16, 38, and 50-54
months. This application proposes to leverage those massive data to follow up the families at ages 5-6, 7-8,
and 9-10. Using state-of-science measures of parents’ and children’s social representations, in Aim 1 we
examine how their unfolding IWMs of each other are linked to their relationship quality, how children’s Theory
of Mind contributes to their IWMs, how children’s IWMs of the parents generalize to their representations of the
social world, particularly hostile attributional biases, and how the child’s IWMs of two parents become integrated
in development. In Aim 2, we examine the parent’s IWM of the child as moderating paths from child difficulty to
parental control, and the child’s IWM of the parent as moderating paths from parental control to child outcomes.
In Aim 3, we embed our model in the dynamics of the family system. Our multi-method, multi-level approach
encompasses observational, genetic, and reported measures of the parent’s and the child’s relational
information processing, representations, temperament, relationships, parental control, and child developmental
outcomes. Variable- and person-centered analyses rely on structural equation modeling to elucidate divergent
developmental cascades. We aim to realize a long-advocated – but yet to be accomplished – vision of research
integrating relationships, temperament, representation, and behavior in pathways to children’s adjustment.

Public health relevance
NARRATIVE This longitudinal research elucidates why some children embark on positive paths toward competent, prosocial, rule-abiding, productive lives with robust socioemotional growth, whereas others enter paths toward poor competence; disregard for conduct rules and others’ welfare; callous, disruptive, and high-risk behaviors; and impoverished socioemotional growth. We study powerful, complex long-term effects of early parent–child relationships, formed in the first years of life and interwoven with the child’s biological individuality, as key to understanding why and how such diverse paths originate in infancy and early childhood. Overall, this research embraces key public health goals by producing evidence-based, fundamental basic knowledge, which can then inform effective parenting intervention and prevention programs that enhance socioemotional growth for our nation’s children and reduce the profound burdens for children, families, and society that can be caused by negative, disruptive developmental trajectories.